Understanding drug delivery through an integrated barcoding approach

Project Summary
Despite being hailed as the “magic bullet” that would selectively target and cure cancer, only a handful of
nanoparticles have been successfully translated to the clinic, and their full potential remains yet to be realized.
In fact, nanoparticle accumulation in tumors continues to be dismally low, with less than 1% of the injected dose
reaching its target. This is largely attributed to the complexity and heterogeneity of both the biological
environment and nanoparticle constructs, making it impossible to deconvolute individual factors contributing to
nanoparticle targeting and accumulation in tumors. Therefore, there is a critical need to better understand and
define the attributes that define successful nanocarriers. This is particularly urgent in lethal cancers that stand to
benefit tremendously from new and targeted therapies, like ovarian cancer, which has a 25% 5-year survival rate
and 70% recurrence rate following chemotherapy, often leading to treatment resistant disease. To develop
effective drug delivery strategies, it is critically important to understand the characteristics of tumors,
nanoparticles, and their interactions, such as by identifying the genetic features associated with high nanoparticle
uptake and accumulation. To accomplish this, the work proposed herein features a chemical barcoding approach
to enable pooled high throughput analysis of nanoparticles in a pre-clinical context, enabling the identification
and correlation of genetic features responsible for successful nanoparticle targeting through a multi-omics
approach. Successful development of this barcoding platform will entail 1) rapid integrated in vitro screening of
pooled NP formulations, 2) in vivo single system evaluation of nanoparticle accumulation at the tissue and cellular
level, and 3) use of pooled barcoded nanoparticles to correlate particle trafficking in patient derived models of
ovarian cancer. This strategy will provide a holistic evaluation of nanoparticle structure-function relationships
with tumor accumulation and enable the identification of genetic components implicated with meaningful
nanoparticle interactions, allowing us to leverage these signatures to develop more effective targeted
nanoparticles to specific tumor cell populations. The proposed work will take place at MIT’s Koch Institute for
Integrative Cancer Research, a premier institution for cancer research with state-of-the-art facilities, under the
mentorship of Prof. Paula Hammond, a renowned chemical engineer and polymer chemist with expertise in the
self-assembly of materials and drug delivery. An advisory team has carefully been assembled, consisting of
Profs. Stuart Schreiber and Angela Koehler for chemical biology and multi-omics analysis guidance, Prof. Joan
Brugge for her cancer biology expertise, and Prof. Nathalie Agar for input on mass spectrometry-based analysis.
Combined, this research proposal and mentorship team will lay the scientific groundwork and provide the
necessary training for the applicant to reach her ultimate goal of successfully starting her independent academic
career at the interface of chemistry, biology, and materials science.

Public health relevance
Project Narrative Nanoparticle translation to the clinic is lacking in large part due to limited accumulation in target disease sites, a particular problem for heterogeneous cancers like ovarian cancer, which can be attributed to the complexity of both the biological environment and the nanoparticle constructs. There is an urgent need to develop tools to deconvolute the individual factors that contribute to nanoparticle accumulation and unlock the unrealized potential of cancer nanomedicine. Therefore, this proposed study seeks to provide a holistic evaluation of nanoparticle structure-function relationships by utilizing a new chemical barcoding strategy to identify materials properties associated with favorable biodistributions and tumor targeting, enable the elucidation of genetic components correlated with nanoparticle interactions, and allow us to leverage the identified genetic signatures for more effective targeted drug delivery.